Evaluation of PEG-BPEI as a potential mitigator against gastrointestinal acute radiation syndrome

ABSTRACT
Gastrointestinal (GI) toxicity remains a significant contributor to mortality following exposure to ionizing radiation
(IR), leading to a severe condition known as GI Acute Radiation Syndrome (GI-ARS). The lack of effective
treatments for GI-ARS has underscored the urgent need for development of medical countermeasures (MCMs)
to mitigate its devastating effects.
To address this unmet medical need, we have developed a murine model of partial body irradiation (PBI) that
simulates a scenario GI injury is created while a small portion of hematopoietic system is spared. This model
allows us to study the specific effects of radiation on the GI tract while minimizing systemic toxicity. Using a
clinical linear accelerator, we have determined the LD50/30, the lethal dose of radiation that kills 50% of the
animals within 30 days, for both male and female mice in this model. This LD50/30 serves as a critical benchmark
for evaluating the efficacy of potential MCMs.
Given the ability of PEG-BPEI to combat bacterial infections by killing both Gram-positive and Gram-negative
bacteria, disabling antibiotic resistance mechanisms, neutralizing endotoxins, and dispersing biofilms, we
hypothesize that it can mitigate leaky gut post-radiation. By reducing the burden of infection, PEG-BPEI may
enhance GI tissue repair, reduce inflammation, and ultimately improve survival rates in mice exposed to ionizing
radiation.

Public health relevance
PROJECT NARRATIVE Given the heightened threat of nuclear attacks and the absence of effective countermeasures for GI-ARS, this proposal aims to evaluate PEG-BPEI as a potential mitigator. We will assess its pharmacokinetics and efficacy in a mouse model of GI-ARS, focusing on both survival and tissue recovery. Successful outcomes will pave the way for further development of PEG-BPEI under the FDA Animal Rule.